Osteocyte energy metabolism in aging

PROJECT SUMMARY
Aging is associated with negative effects on the skeletal system, leading to impaired bone health, increased
frailty, and risk of musculoskeletal disorders. However, our current understanding of the mechanisms by which
aging affects skeletal health is limited. Osteocytes are the most numerous and long-lived cells in bone and play
key roles in maintaining bone mass by responding to anabolic signals such as mechanical loading. This response
to loading is impaired in aged bone, by unknown mechanisms, leading to derangements in bone homeostasis.
Energy metabolism is disrupted in many cells and tissues with aging, however regulation of energy metabolism
in osteocytes and how this is affected during aging and by mechanical loading remains undefined. Our
preliminary findings have identified that anabolic mechanical loading regulates energy metabolism in osteocytes
in vitro and in vivo. Specifically, fatty acid β-oxidation is upregulated in response to strain, as are the key
promoters of β-oxidation, peroxisome proliferator-activated receptor delta (Pparδ) and carnitine
palmitoyltransferase 1 (Cpt1). Deletion of Pparδ in osteocytes in vivo inhibited β-oxidation and decreased bone
mass in female mice but not males. Furthermore, β-oxidation is decreased in aged mouse bone compared to
young animals, and pharmacological activation of PPARδ in aging mice improves bone health. These findings
suggest important functions of osteocyte energy metabolism, and β-oxidation in particular, in the effects of aging
and mechanical loading on bone.
In this proposal, we will determine the role of osteocyte β-oxidation in the response to mechanical stimulation
and the maintenance of bone health with aging. For these studies, we have generated mice with targeted deletion
of Pparδ in osteocytes and will use these mice and ex vivo isolated osteocytes from young and aged mice to
determine the function of β-oxidation in osteocytes. In Aim 1, we will determine the role of osteocyte β-oxidation
in regulating bone health in young and aged mice. In Aim 2, we will determine how aging affects the metabolic
response of osteocytes to mechanical loading and the role of PPARδ-driven β-oxidation in this process. In Aim
3, we will examine whether activation of PPARδ to increase β-oxidation in osteocytes can improve bone health
in aged mice.
The findings from the proposed studies will markedly increase the knowledge of osteocyte energy metabolism
and define the role of PPARδ-driven β-oxidation in osteocytes and its function during aging and under
mechanical loading.

Public health relevance
PROJECT NARRATIVE The mechanisms behind impaired skeletal health with advancing age are still unclear, however defective energy metabolism is known to be associated with aging in multiple tissues. This proposal will investigate the role of energy metabolism in osteocytes, key regulatory bone cells, in response to mechanical loading and during aging. This work will enable us to identify novel strategies to maintain bone health during aging by targeting osteocyte energy metabolism.